Understanding the Role of VA Specialty Care Resource Hubs and Their Potential Impact on Access in the Era of Community Care

Project Summary: Not required.

Public health relevance
As VA expands access to community care under the MISSION Act, VA’s ability to optimize timely access in its own facilities will significantly impact how much care will be outsourced to community settings. Recognizing this, Title IV of the MISSION Act directs VA to improve health care access in medically-underserved VA facilities through use of novel healthcare delivery models such as regionalized virtual care resources that can be flexibly deployed across facilities according to need and strategic expansion of graduate medical education (e.g., “residency” and “fellowship”) training positions. Primary care and mental health virtual care clinical resource hubs are currently being piloted in several VISNs, and VA ORH anticipates deploying specialty care resource hubs (SCRHs) in FY 2021. This planning grant will lay the groundwork for future research assessing the impact of centralized specialty care delivery through SCRHs on important Veteran-centered outcomes and examining the role of innovative strategies such as integrating specialty trainees to deliver care in this manner.